Targeted circuit modulation to delineate the causal role of oscillatory interactions in top-down networks of cognitive control

PROJECT SUMMARY – UNIVERSITY OF NORTH CAROLINA-CHAPEL HILL, FROHLICH
Sustained attention represents a fundamental dimension of cognitive control and refers to the process of allocating
cognitive resources to appropriately respond to infrequent but task-relevant stimuli. Sustained attention differs from
the more commonly studied shifting or dividing attention since it lacks the defining features of capacity limitation and
competition. Deficits in sustained attention are common in psychiatric illnesses including attention deficit hyperactivity
disorder, bipolar disorder, and schizophrenia. Understanding the network substrate of sustained attention will thus
significantly advance our ability to develop circuit-based therapeutics that selectively engage and restore the activity
patterns that drive sustained attention. Synchronization in two higher-order networks have emerged as neural sub-
strate of sustained attention and cognitive control in general. First, the frontoparietal network acts as a generator of
top-down control signals. Second, the posterior thalamo-cortical network gates processing of input and exhibits task-
modulation during sustained attention. Yet, it remains unclear if the synchronization through oscillations in these two
networks plays a causal in sustained attention and more broadly in cognitive control. Targeted brain stimulation of
individual network nodes with rhythmically patterned stimulation offers the opportunity to manipulate specific network
oscillatory patterns and examine the resulting change in behavioral performance to establish a causal role of the
targeted activity pattern. Such causal neuroscience of higher-order brain function will fundamentally advance our
understanding of how cognition arises from large-scale electrical activity patterns in the brain. The overall objective is
to identify the causal role of oscillatory functional interactions in sustained attention by rhythmic optogenetic stimula-
tion. We will employ a widely used paradigm of sustained attention in animals, the five-choice serial reaction time
task (5-CSRTT), in combination with rhythmic optogenetic stimulation and multisite electrophysiology in ferrets. We
use the ferret (instead of more commonly used rodent species) for the study of the oscillatory substrate of cognitive
function since we previously found that the ferret shares two fundamental top-down brain rhythms with humans:
frontal theta oscillations that provide control of posterior parietal cortex and posterior alpha oscillations that gate
visual perception. The proposed project builds on our published work of oscillatory interactions in these two networks
as a function of engagement with both the 5-CSRTT and sensory input in ferrets, and our preliminary data of suc-
cessful modulation of neuronal spiking, functional connectivity, and behavioral performance in the 5-CSRTT by fre-
quency-specific rhythmic optogenetic stimulation. We hypothesize that oscillatory functional interaction in these two
networks is dynamically regulated to drive sustained attention in this task. Completion of these three aims will pro-
vide an in-depth understanding of the causal role of frontoparietal and posterior thalamo-cortical network in sustained
attention. The rationale of this project is that advancing the causal investigation of synchronization in higher-order
brain structures in cognitive control will open new avenues for the development of novel diagnostic and therapeutic
strategies for deficits in cognitive control. The proposed work is thus of high translational significance and broad
impact since sustained attention is impaired in numerous psychiatric illnesses.

Public health relevance
PROJECT SUMMARY - UNIVERSITY OF NORTH CAROLINA-CHAPEL HILL, FROHLICH The proposed research is relevant to public health since establishing the causal role of network dynamics during sustained attention will ultimately enable the design of novel brain stimulation treatment strategies for impairment of sustained attention, which is common in psychiatric illnesses. Thus, the proposed research is relevant to the NIH’s mission to foster innovative research strategies to improve human health.